TRAINING PROGRAM IN MECHANISMS OF VIRUS-HOST INTERACTIONS

DESCRIPTION (provided by applicant): The Mechanism of Virus-Host Interactions Training Grant is a multidisciplinary training program designed to train and educate pre-doctoral and post-doctoral trainees in the broad discipline of Virology. This proposal requests continued support for the Virology training program. The faculty is derived from two research institutions, the Mount Sinai School of Medicine (MSSM) and the NYU School of Medicine (NYUSM). The research training emphasis is directed toward teaching pre-doctoral and post-doctoral trainees the theory and experimental approaches required for independent scientific investigations. Students learn the molecular mechanisms involved in virus replication and host responses to viral infections. Research training areas also include novel approaches for antiviral strategies and vaccine development against medically relevant viruses. Our trainees are highly successful in attaining independent research positions, peer-reviewed publications, and extramural research funding. Accordingly, six pre-doctoral and six post-doctoral positions are requested. The specific aim of the program is to recruit and provide rigorous training to high caliber students and fellows. The continued support of this program will aid trainees in all phases of their development including understanding scientific method, interpretation of results, presentation of data and conclusions, research ethics, and career guidance. By combining the strengths of an outstanding group of virologists, we have created a world-class virology training program. This program is built upon existing collaborations, including research grants, and joint publications between faculty members at MSSM and NYUSM. Accordingly, our collaborative training effort has added value over single institution or individual based initiatives. The program faculty consists of twenty-eight outstanding virologists who use a diverse array of experimental strategies to study the molecular, cellular, biochemical and immunological interactions of viruses with their hosts. RELEVANCE: The Mechanism of Virus-Host Interactions Training Grant is vital to the development of the next generation of virologists. These trainees will be leaders in the field of Virology developing strategies to prevent and limit virus pathogenesis.